DREAM Complex Maintenance of Human Beta Cell Quiescence

Summary
Types 1 and 2 diabetes result entirely or in part from a reduction in numbers of normally functioning pancreatic
beta cells. Residual beta cells are present in most people with diabetes, suggesting that regenerative therapies
may be uniquely helpful. Inducing human beta cells to regenerate has proven impossible until recently. This
has changed with the discovery by several labs of drugs that inhibit the kinase, DYRK1A, and which induce
human beta cells to replicate at “rates”, or more properly, “labeling indices”, of ~2%. Proliferation can be
augmented by combining DYRK1A inhibitors with TGF-beta superfamily inhibitors or with GLP1 receptor
agonists, generating labeling indices of 5-8%. Although these are exciting advances, they also demonstrate
that >90% of human beta cells are recalcitrant to cell cycle entry. The cause of this remarkable refractoriness
to proliferation is poorly understood.
DYRK1A inhibition alters intracellular trafficking of the NFaT family of transcription factors. In the course of our
studies on human insulinomas, we have uncovered a parallel pathway, the DREAM-MMB complex, that also
restricts human beta cell proliferation. We show here that the extended family of ~200 canonical DREAM-MMB
complex genes and proteins appear to be present in human beta cells, and that DREAM complex is switched
from a repressive to a proliferative configuration by DYRK1A inhibition. In addition, we have also observed
potential overlapping roles for Trithorax and Polycomb complexes with the DREAM complex in restraining
human beta cell proliferation. Accordingly, in this application, we propose three Specific Aims:
Aim 1. Complete The Characterization of the Functional DREAM-MMB Complex in the Human Beta Cell.
Aim 2. Delineate Candidate DREAM-MMB Complex Target Genes in the Human Beta Cell.
Aim 3. Aim 3. Define Genome-Wide Integration of Repressive and Proliferative DREAM-MMB Mediators
with Trithorax and Polycomb Chromatin Regulators and DREAM Target Genes in Human Beta Cells.
Our overarching goals are: 1) to clearly and comprehensively define the fundamental mechanisms that enforce
quiescence in the adult human beta cell; 2) to more clearly elucidate the fundamental mechanisms through
which DYRK1A inhibitors, TGFβ inhibitors and GLP1RA’s synergize to induce their remarkable rates of human
beta cell proliferation; and 3) to reveal novel pathways and further expand therapeutic targets for human beta
cell regeneration for diabetes.

Public health relevance
Narrative Types 1 and 2 diabetes represent a global health crisis, and result in part or entirely from a reduction of insulin- producing pancreatic beta cells. Despite the existence of ~30 different commercially available diabetes drugs, none has the ability to induce human beta cell regeneration. We describe herein entirely novel and tractable pathways to human beta cell proliferation, and have identified multiple combinations of drugs that act via these pathways to induce human beta cells to regenerate.